Interplay between Type I IFN and TGF-beta signaling in systemic sclerosis

DESCRIPTION (provided by applicant): Although it is generally agreed that transforming growth factor-beta (TGFβ) plays a central role in sustaining fibrosis in systemic sclerosis (SSc), the triggers of TGFβ, TGFβ activation and TGFβ intracellular signaling are still unknown. The goal of this grant is to understand how TGFβ signal activation is up-regulated in SSc focusing on the link between innate immunity, inflammation and fibrosis. New emerging evidence points to the importance of innate immunity and interferons (IFNs) in many autoimmune diseases including SSc, and we found that in addition to upregulated TGFβ gene expression SSc skin and peripheral blood mononuclear cells (PBMC) also show upregulated IFN gene expression. Interestingly more recently we found that polyIC, a toll like receptor 3 (TLR3) ligand, activates human fibroblasts (fb), inducing not only genes known to be regulated by IFNs but also genes that are induced by TGFβ, suggesting that TGFβ activation and then fibrosis is regulated by the innate immune response. Thus this application proposes to investigate how innate immune activation regulates inflammation and scarring through cross talk between IFNα/βand TGFβ. One of the most exciting of our preliminary results is that polyIC and IFN¿ both induce Smad1 phosphorylation, indicating crossactivation of TGFβ signaling by IFNα/β. In addition we unexpectedly discovered that IFN¿ a receptor 2 (IFNAR2) in mice deficient of the IFN¿ receptor 1 (IFNAR1 -/-) activates a non classical IFNα/β pathway, and that this pathway may be involved in entirely new biological functions such as controlling the induction of TGFβ signaling components. In the first aim, proposed experiments will examine the mechanism controlling the physiologic balance between the induction and suppression of the pro-inflammatory program through cross talk between IFN and TGFβ in fb from wild type (WT) mice, studying Smad1/2/3 expression and phosphorylation, IRF7 and Smad7 gene expression. Then we will investigate the consequences of aberrant IFN signaling that promote novel cross talk between IFN and TGFβ, and causing the modified equilibrium in TLR activation promoting the profibrotic phenotype in fb from IFNAR1-/- mice. Aim 2 will explore whether impairment of IFNα/β signaling might underlie the pro-fibrotic phenotype that characterizes SSc fb, as we observed in IFNAR1 -/- fb. Experiments in this aim will test the effect of IFN¿ and polyIC on TGFβ signaling components and the functioning of INFα/β signaling in SSc compared to normal fb. Finally we will examine the in vivo expression of selected IFNα/β and TGFβ mediators IRF7 and Smad7, in SSc and control skin. Together, these results should significantly extend our understanding of the role of innate immune activation, IFNs and TGFβ in dermal fibrosis, enlightening a new standpoint of SSc pathogenesis that IFNα/β impairment might be the primary cause of uncontrolled TGFβ activation. In addition the new finding of IFNAR2 function in controlling activation of TGFβ signaling, add a novel biological response to the complexity of IFN-mediated signaling potentially influencing the clinical use of therapeutics targeting IFNs not only in SSc but also in other diseases.

Public health relevance
Fibrosis, a form of scarring, is responsible for the majority of clinical problems in patients with diffuse cutaneous systemic sclerosis (SSc), a disease that involves the skin, lung, kidney and gastrointestinal tract. Little is known about. The major goal o this project is to identify the interaction between interferon (IFN), a key signal of inflammation, and transforming growth factor-beta (TGFβ), a key signal for scarring/fibrosis interact to cause fibrosis in SSc, in skin cell known as fibroblasts during inflammation. These studies are likely to provide important information about how these mediators cause scarring/fibrosis in SSc and also toward planning of clinical trials using medicines designed to interfere with these mediators in patients with SSc.